Multidisciplinary Implementation Research for malaria control and elimination in West Africa

Abstract
Despite a substantial reduction in the incidence and deaths related to malaria in sub-Sahara Africa, the region
still carries a disproportionate share of the global burden of malaria. The overall goal of this ICEMR program is
to understand the persistence of malaria in the context of the wide deployment of control interventions and
provide evidence-based approaches for developing optimal combinations of control strategies for interrupting
residual malaria transmission. We will characterize critical barriers related to changing epidemiological patterns
and drug and insecticide resistance to develop contextually tailored interventions to address the evolving needs
of malaria control programs. This ICEMR encompasses 3 Projects with the goals summarized as follows: 1]
Epidemiology Project (Project 1): the goal is to investigate the residual malaria transmission to develop and
evaluate optimal control strategies at study sites in Mali, representing different eco-zones across West Africa,
2]Malaria immuno-genetics Project (Project 2): The goal of this project is to study factors associated with
gametocytogenesis in symptomatic and asymptomatic disease and their contributions to transmission in low
transmission season setting (parasite and human genetics, immune response, and transmissibility) in relation
with malaria control interventions in Mali, 3] Malaria vector and transmission field ecology project (Project 3):
will characterize low residual transmission studying malaria vector populations and ecology in the continuum
rural-urban and peri-urban setting of Bamako, Mali. These projects link the different aspects of malaria
transmission and disease into a unified whole, adding the ability to distinguish the contributions of different
malaria control interventions on parasite population and range of immune responses (Project 2,
Immunopathogenesis) and seasonal and geographical distribution of anopheline mosquitoes vectors (Project 3).
Understanding the factors relating entomological with epidemiological transmission patterns will provide more
appropriate guidelines for malaria control tailored to different ecological settings in Mali and West Africa.

Public health relevance
Project Narrative: Sub-Saharan Africa region continues to bear the brunt of the global malaria burden despite wide deployment of control interventions. This multidisciplinary program will contribute to improve our understanding of the changing malaria epidemiology and transmission in relation with control interventions. We will developpe, evaluate and optimize ongoing malaria control strategies to produce maximum impact on transmission interruption and elimination through implementation research. We will characterize critical barriers related to changing epidemiological patterns, drug and insecticide resistance to develop adaptive evidence-based interventions to meet the evolving needs of control programs.